Sample Collection and General Screening Protocols

During FY25, healthy volunteers were enrolled in the Vaccine Research Center Clinical Trials Program screening protocol, VRC 500 (NCT01375530), to assess healthy volunteers for eligibility in the following trials: a bispecific HIV monoclonal antibody targeting the HIV envelope protein (VRC 617; NCT06585891), a hexavalent mosaic full-length hemagglutinin protein nanoparticle influenza vaccine without an adjuvant (VRC 326, NCT05968989), a hexavalent mosaic full-length hemagglutinin protein nanoparticle influenza vaccine with and without adjuvant (VRC 328, NCT06863142), and a quadrivalent stem hemagglutinin protein nanoparticle influenza vaccine with and without an adjuvant (VRC 329, NCT07111078).